Novel Bladder Catheterization Device

Project Summary/Abstract
This project relates to the development of a novel catheterization device which will create a new method for
bladder drainage. It is estimated that over one million Americans, including tens of thousands of children, have
a neurogenic bladder (bladder failure) requiring use of a catheter to drain urine. This includes over 250,000
people with spinal cord injury, 120,000 people living with spina bifida, and a subset of the tens of millions of
Americans living with prostate enlargement, diabetes, multiple sclerosis and other neurogenerative diseases. Up
to 10 percent of patients in long-term care facilities are catheter-dependent. Current bladder management
methods are associated with significant morbidity and inconvenience. Developing a simple, reliable, and safe
catheterization approach would provide a novel bladder drainage method in a field where meaningful innovation
is necessary. The proposed project explores a novel bladder catheterization system with several innovative
features. A prototype device will be developed and evaluated.

Public health relevance
Project Narrative Many people with bladder failure (neurogenic bladder) rely on catheters to drain urine from their bladder. Current catheter options for bladder drainage are associated with significant health problems, inconvenience, and embarrassment. An alternative bladder drainage device that is reliable, safe, and convenient for patients and caregivers to use would improve health and quality of life outcomes for people with bladder failure.